Mechanism and regulation of Hu family RNA binding proteins during neural alternative polyadenylation

PROJECT ABSTRACT
3' untranslated regions (3' UTRs) are the hubs of post-transcriptional regulation,
and contain the majority of binding sites for regulatory factors such as miRNAs and RNA
binding proteins (RBPs). Moreover, it has recently become appreciated that most genes
do not express a single 3' UTR, but instead express multiple 3' UTR isoforms through a
process known as alternative polyadenylation (APA). Since APA can be deployed to
coordinately shift the 3' UTR profiles of large cohorts of genes according to tissue
identity, environmental condition, or disease status, APA can broadly affect the post-
transcriptional landscape and profoundly impact gene expression programs.
Nevertheless, very little remains known about the underlying mechanisms of how global
APA programs are enacted. In ongoing work, we identify conserved, redundant roles for
Hu family neural RBPs in driving a broad program of neural 3' UTR lengthening in both
Drosophila and mammalian nervous system. Here, we will use molecular genetic assays
and genomewide analyses to elucidate the mechanism for neural Hu proteins in
conferring neural 3' UTR extensions. Since neural Hu factors have such powerful
capacity to remodel the transcriptome, it may follow that they are under strict control.
Indeed, we have also found that neural Hu genes in both Drosophila and mammals are
subject to unexpectedly complex and strong post-transcriptional suppression outside of
the nervous system. We have developed new genetic models to study these regulatory
mechanisms and their phenotypic impacts, which may reveal new roles for these factors
in developmental patterning and also have tangible implications for a class of human
disease that is caused by misexpression of neural Hu proteins outside of the brain.
Overall, this work will reveal new perspectives on the deployment of the distinctive
neural post-transcriptional landscape and its in vivo biological importance.

Public health relevance
PROJECT NARRATIVE It has recently become appreciated that alternative polyadenylation (APA) causes a majority of genes to express multiple 3'UTR isoforms, resulting in radical differences in post-transcriptional regimes. We are studying a conserved phenomenon by which 3'UTRs are broadly extended in the nervous system of Drosophila and vertebrates via Hu family RNA binding proteins (RBPs), and reciprocally, how the activity of Hu genes is restricted by powerful post-transcriptional mechanisms. This work informs how a defining feature of the distinctive neural transcriptome is generated, and more generally, may shed light on how 3'UTR landscapes can be altered by RBPs during disease and cancer.